Invasive Pneumococcal Disease and Carriage among Children with Sickle Cell Disease in Ghana: A Post-vaccination Study

PROJECT SUMMARY
Pneumococcal carriage is the precursor for development of pneumococcal disease, and is also
responsible for transmission of the organism from person-to-person. Children with Sickle Cell
Disease (SCD) are particularly susceptible to invasive pneumococcal disease (IPD) due
to the i n a b i l i t y of their defective immune system to effectively handle encapsulated
bacteria. This has led to the recommendation of anti-pneumococcal prophylaxis for SCD
children including the administration of penicillin and the 23-valent polysaccharide vaccine
(PPV23) in the past. Though these prophylactic measures decreased the rate of IPD among
SCD children, breakthrough disease still occurred, mostly in children aged <3 years. In the last
decade, Pneumococcal Conjugate Vaccines (PCVs) have become available in about 80% of the
countries in sub-Saharan Africa. Epidemiological evidence from various studies indicate that
PCVs can cause a shift in the distribution of pneumococcal serotypes usually towards non-
vaccines types in both carriage and disease. In areas of high SCD prevalence in sub-Saharan
Africa, pneumococcal surveillance data following introduction of PCVs remain scarce. The goal
of this proposed study is to understand the epidemiology of pneumococcal carriage and
invasive disease among children with SCD in the post-conjugate vaccine era in Ghana. To
address this goal, we will execute three specific aims as follows: (i) to determine the frequency
of pneumococci acquisition in SCD children vaccinated with PCV13 and evaluate the common
serotypes carried and their persistence. (ii) to determine the incidence of IPD and the causative
serotypes among children with SCD. (iii) to evaluate the antibiogram of pneumococci isolated
from children with SCD and describe the penicillin and / or multidrug resistant clones.
Information from the study would be useful in the prevention and management of pneumococcal
infections among children with SCD in Ghana.

Public health relevance
PROJECT NARRATIVE The proposed research project aims to understand the epidemiology of Streptococcus pneumoniae with respect to children with sickle cell disease in the era of pneumococcal conjugate vaccines. The methods involve longitudinal carriage studies and surveillance of invasive pneumococcal disease. Information generated from the project would be useful in designing preventive and management strategies to protect children with sickle cell disease against pneumococcal infections.